HYPOTHALAMIC PITUITARY ADRENAL AXIS DYSFUNCTION IN PATIENTS WITH PTSD

This protocol will study World War II or Korean War veterans with Post Traumatic Stress Disorder. The primary contribution to this will be the basic patho-physiologic process that may occur in subjects with combat related PTSD. This may provide a building block to utilizing HPA measures in the diagnosis and treatment of PTSD and may be useful in predicting response to traditional treatments.